Bacterial Manganese Homeostasis

PROJECT SUMMARY
Manganese (Mn) is a trace nutrient that is essential for viability of organisms from bacteria to humans. Mn serves as
an enzyme cofactor to help catalyze diverse chemical reactions. Mn also detoxifies and protects cells from reactive
oxygen species. For these reasons, many pathogenic and symbiotic bacteria require Mn to survive in eukaryotic host
tissues. However, excess Mn can be toxic. Therefore cells must carefully regulate the intracellular levels of Mn
through homeostasis systems. In addition to a Mn importer and exporter, a small protein of only 42 amino acids
called MntS helps control intracellular Mn levels in Escherichia coli. Despite its phenotypic connection to Mn
homeostasis, many aspects of the regulation and binding interactions of MntS are not understood.
MntS is a member of the poorly-characterized class of small proteins (< 50 amino acids) that have unique
structural and functional properties due to their short length. Although few of the vast number of predicted small
proteins have been characterized, one emerging theme is their interaction with and regulation of larger proteins. We
have demonstrated that MntS binds and inhibits the Mn exporter MntP in E. coli. We have also showed that MntS
evolved from the signal peptide (SP) region of the SitA Mn importer. Surprisingly, the SitA SP alone can function
like MntS, making it the first example of a dual-function SP in gram-negative bacteria. Even less is known about
cleaved functional SPs than small proteins, but with a demonstrated activity in Mn homeostasis, the SitA SP is a
promising entry into characterizing fundamental aspects of bacterial SPs with second functions.
Our overall goals are to uncover the mechanism of action of the model small protein MntS in Mn homeostasis
and to use lessons learned from MntS to understand other small proteins. We also aim to use principles identified
from studying the functional SitA SP to address basic questions about how these SPs are produced and localized in
cells. In Aim 1, we will systematically identify mutants of MntS and MntP that disrupt their interactions. We will
also test whether MntS binding causes MntP degradation. In Aim 2, we will investigate how the MntS protein is
regulated by proteolysis. We will identify the sequence determinants in MntS that lead to its rapid cellular turnover,
as well as the cellular determinants causing its degradation. In Aim 3, we will characterize how the functional SitA
SP is produced in cells and where in the cell it functions, with the goal of determining important features of the SP
that may allow us to find additional functional SPs.
These studies will give mechanistic information about Mn homeostasis in E. coli and related enterobacteria that
may enable scientists to manipulate bacterial populations in eukaryotic hosts or the environment. In the long-term,
these findings may help decrease disease by allowing us to eliminate pathogenic bacteria and aid growth of
beneficial bacteria. Additionally, fundamental knowledge gained about functional SPs and small protein
biochemistry and physiology from these studies will further understanding of how cells function and could be used
to design novel small proteins with specific desired functions.

Public health relevance
PROJECT NARRATIVE Many pathogenic and symbiotic bacteria require the metal manganese to survive in eukaryotic hosts, like mammals and plants. This project will determine the mechanism of action of a small protein of only 42 amino acids in manganese homeostasis in the model bacterium Escherichia coli. As small proteins are a newly-recognized class of proteins with unique features that could be exploited as biotechnology reagents, this study will not only increase understanding of bacterial survival and growth in stressful environments, but will provide insight into a poorly- understood type of gene to expand fundamental knowledge of how cells work.